Medicinal Chemistry Core

SUMMARY
The Medicinal Chemistry Core (MCC) will provide synthetic and medicinal chemistry, cheminformatics, and
structure-based design resources complementary to those existing within the respective project teams. It will
integrate tightly with the other Cores. The MCC resource will distinguish itself by relying on extensive
pharmaceutical medicinal chemistry experience in antibacterials melded with academic strengths in drug
discovery and development. Critically, the MCC staff leadership has demonstrated an ability to produce drug
candidates by evolving small molecules to address a wide range of problems encountered during the lead
optimization process. This experience will be essential to: Project 1) the lead optimization of novel rifamycins to
reach the desired product profile for Mycobacterium abscessus treatment, Project 2) the lead optimization of
an indazole sulfonamide for the treatment of Mycobacterium avium infection, Project 4) the delivery of a novel
tarocin:β-lactam combination product suitable for the treatment of Staphylococcus aureus and Staphylococcus
epidermidis infections, and Project 5) the delivery of an arylmyxopyronin for drug-resistant bacterial infections.
These projects necessitate experience with a diverse range of chemistries as found in the description of the
MCC member backgrounds. Overall, the spectrum and depth of the MCC staff's industrial and academic
background will prove critical to their ability to optimize leads within the individual projects to molecules with
significant potential for positively impacting the antibacterial clinical landscape to address the global health
crisis.